NNLM All of Us Community Engagement Center Extension

Project Summary Statement With expanded focus on community-engagement and partnership, the University of Iowa will continue to serve as the Network of the National Library of Medicine (NNLM) All of Us Community Engagement Center (CEC), serving as the single center for all NNLM engagement activities that support awareness of and build interest in the All of Us Research Program (All of Us). The CEC will use agile principles and community-based participatory engagement strategies to engage NNLM members, All of Us engagement ecosystem partners, national library organizations, and NNLM Regional Medical Libraries, Offices, and Centers (ROCs) in engagement initiatives that will provide awareness of All of Us and support the health and well-being of individuals, families, and communities through information access. In the year 2021-2022, CEC will use feedback from partners and evaluation data to expand and improve our virtual engagement activities and to strengthen and renew partnerships. The CEC will collaborate with the All of Us Training & Education Center (TEC) to develop shared statements/visions, tools, and methodologies. Through this approach, the CEC team will achieve two specific aims. These aims will be carried out by a team that has expertise in libraries, community engagement, virtual programming, health literacy, digital literacy, citizen science, cultural humility, cross-disciplinary collaboration, communications, project management, evaluation, and needs assessment. This combination of expertise and collaboration positions the CEC to achieve its goals over the next year to continue moving the pilot in to a full-scale program.

Public health relevance
Project Narrative This project will continue and expand the community outreach efforts of the Network of the National Library of Medicine (NNLM) All of Us National Program (AoUNP) by having the Community Engagement Center as the single center for all AoUNP engagement activities that support awareness of and build interest in the National Institutes of Health (NIH) All of Us Research Program (All of Us). The proposed project is relevant to NNLM because a centralized and coordinated effort to engage with NNLM's community partners and All of Us partners will allow AoUNP to implement community-based participatory engagement processes effectively. Input from community members will ensure that resources and programs developed by AoUNP will be relevant and appropriate for the communities targeted by AoUNP, particularly those underrepresented in biomedical research.